Elucidating glial diversity in the peripheral nervous system

Peripheral nerve assembly requires the coordinated development of many components, including axons and the glial cells that ensheath them. Currently, we have a broad perspective of the structure of peripheral nerves and the events that govern nerve assembly. However, we still lack a complete picture of all of the cellular and molecular mechanisms that mediate these events, and whether perturbations to these processes underlie disease. This is in part due to the fact that we still don’t have a full appreciation of the diversity of glial populations that make up these structures and there are currently no specific markers for any peripheral glial population. Additionally, although peripheral nerves are often grouped together as a single, uniform structure, there are in fact many types, including cranial, trunk, sensory, and motor, as well as spatial organization along the proximal-distal axis. However, whether there is any glial diversity between or along these structures, and whether this diversity is what contributes to the differences observed between these nerves with respect to function and susceptibility to disease, has yet to be determined. Using single-nuclei RNA-sequencing coupled with the powerful system, zebrafish, we will create a molecular taxonomy of peripheral glial subpopulations and decipher their roles in nervous system development.

Public health relevance
In this proposal, using zebrafish as a vertebrate model, we will add to our understanding of peripheral nervous system development by identifying and investigating the role of several glial populations, including perineurial glia, motor exit point (MEP) glia, and Schwann cells, in the same intact organism, simultaneously. By coupling single-nuclei RNA-sequencing, multi-color, in vivo, time-lapse imaging, genetic perturbation, pharmacological manipulation, fate-mapping, and single-cell laser ablation, our studies will identify glial diversity, lead to a fundamental understanding of the rules that form functional nervous systems, and will also shed light on mechanisms that could be perturbed in disease and after injury.